CHARGE NEUTRALIZATION

The major objectives of this project are (1) to provide an understanding of charge neutralization and (2) develop instrumentation and general experimental procedures that allow the full potential of state-of-the-art ESCA spectrometers to be attained for nonconducting polymeric biomaterials. Data interpretation consistent with the complete ESCA data set (elemental composition, high-resolution spectra, and valence band spectrum) will be stressed.